IGF::OT::IGF Logistical support services for event titled, "Understanding Health Disadvantages Across High Income Countries Think Tank" to be held on April 5-6, 2016

Logistical support services for event titled Understanding Health Disadvantages Across High Income Countries Think Tank.